Photoredox-Enabled C-H Functionalization: Polyoxometalate Mediated Alkane Arylation and Redox-Gated Tyrosine Amination

PROJECT SUMMARY/ABSTRACT Many of the medicines, materials, and agrochemicals important to modern society are constructed using synthetic organic chemistry. Throughout the past 50 years, transition metal-catalyzed cross-coupling methodologies have become indispensable to the practice of organic chemistry due to their general and predictable ability to construct carbon-carbon and carbon-heteroatom bonds. C–H bonds represent an ideal latent nucleophile in this context due to their abundance as well as the atom- and step-economy of direct C–H functionalization. Aim 1 of this proposal describes how the combination of polyoxometalate catalysis and transition metal catalysis would enable the generation of alkyl radicals from strong, neutral alkyl C–H bonds that can be intercepted by transition metal catalysts to forge carbon-carbon bonds. Aim 2 of this proposal focuses on the selective photoredox-mediated C–H amination of native tyrosine residues in peptides and proteins. Such conjugated products are of high value in drug development, medical imaging, hybrid material engineering, biochemistry, and chemical biology. The ability to use light as a mild driving force coupled with the use of C–H bonds as ideal coupling partners would improve the means by which a variety of important chemical scaffolds are accessed.

Public health relevance
PROJECT NARRATIVE The construction of carbon-carbon bonds in pharmaceuticals, materials, and agrochemicals directly from the corresponding C–H bonds is desirable based on atom- and step-economy, and Aim 1 of this proposal describes an innovative dual-catalytic platform to enable these transformations. Aim 2 focuses on a selective bioconjugation to native tyrosines in peptides and proteins which will enable efficient access to modified peptides and proteins, a class of molecules which are highly useful in drug development, medical imaging, hybrid material engineering, biochemistry, and chemical biology. Both aims thus improve access to a range of organic and biological compounds that could be used to enhance health, lengthen life, and reduce illness and disability.